Center for AIDS Prevention Studies (CAPS)

PROJECT SUMMARY
The Center for AIDS Prevention Studies (CAPS) is a highly productive, vibrant, integrated, multidisciplinary
center that conducts cutting-edge, high-impact HIV prevention research with robust institutional support from
one of the highest ranked medical schools in the country. CAPS has a multidisciplinary faculty who conduct
research driven by the center's mission. CAPS's significant contributions to HIV science are evident in the over
553 manuscripts published during the current award period (9/01/2016-6/30/2020). CAPS has continued to
catalyze HIV science by obtaining NIH research grants at an almost 60% success rate and has grown a
diverse portfolio that addresses the continuum of HIV prevention and treatment. This portfolio spans basic
social and behavioral science to intervention development, implementation and policy research. The significant
and ongoing scientific contributions of CAPS necessitate the center continue its leadership in advancing the
next generation of research required to end the HIV epidemic.
We will continue to provide critical support to a cadre of world-class scientists who push disciplinary
boundaries. This will be accomplished via an agile infrastructure of research cores designed to ignite scientific
innovation and high-impact research with the depth and breadth necessary to reach global indicators for
ending the epidemic. Overall, CAPS aims to:
1. Catalyze a strong scientific environment: Ignite timely, innovative, high-impact, multidisciplinary
research to nimbly address current and emerging issues critical for ending the HIV epidemic, particularly
those related to the center themes;
2. Strengthen the scientific workforce: Build the number, competence, capacity, effectiveness, and
diversity of investigators, as well as community and public health partners to conduct high-priority, high-
impact HIV research that is responsive to addressing co-occurring and multiplicative factors driving HIV
and HIV-related health systems;
3. Advance innovative methods: Promote the use of novel research designs, integrative methods, and
cutting-edge technologies that are necessary for addressing the complex, multilayered, co-occurring,
multiplicative factors and strategies that facilitate rather than hinder access to HIV prevention and
treatment within HIV-related health systems;
4. Maximize public health impact: Bridge the gap between research and practice by supporting research
that ensures that efficacious interventions and practices translate optimally and equitably into effective
implementation within and across diverse community and health systems.
In summary, consistent with NIMH Division of AIDS Research's areas of high priority,3 CAPS will drive
progress towards an end to the HIV epidemic by catalyzing and supporting innovative, multidisciplinary HIV
research that integrates and sustains HIV prevention and treatment delivery across diverse health systems to
address the co-occurring and multiplicative factors that drive the epidemic.

Public health relevance
PROJECT NARRATIVE Since its inception, the Center for AIDS Prevention Studies (CAPS) has been at the forefront of conducting theory-driven, rigorous research to prevent new HIV infections, improve health outcomes among those infected and reduce significant HIV-related health disparities. The Center will build on its long and successful history of providing critical support to its cadre of world-class scientists that conduct interdisciplinary research to achieve an end to the HIV epidemic. .